National Xenopus Resource Center

Project Summary
This grant supports a project to purchase equipment to replace aging parts of our recirculating aquatic
systems. This will ensure proper operation of animal housing and animal welfare. The National Xenopus
Resource houses over 10,000 frogs and it is essential that we maintain our equipment to reduce the chances
of failure.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research, including cell biology, development, neurobiology, physiology and signal transduction, achievements that are supported by having a centralized National Xenopus Resource for raising and distributing animals and disseminating the most current technology to the research community. In each of these areas research has led to significant insights about the causes of human diseases, including cancer, birth defects, diabetes and neurological disease, and provided key underpinnings for the field of regenerative medicine.